Optimizing Betamethasone Therapy for Preventing Respiratory Distress Syndrome in Twin Pregnancy

PROJECT SUMMARY
Twin pregnancies account for approximately 3% of all births in the U.S. Twin pregnancies show distinct
physiological differences compared to singleton pregnancies that can impact the efficacy and safety of drugs
used during pregnancy. Betamethasone is a synthetic corticosteroid that is used in pregnant women who are at
risk for preterm delivery to promote fetal lung maturation and to reduce the incidence of respiratory distress
syndrome (RDS) in neonates. However, our understanding of the impact of these physiological changes in twin
pregnancies on pharmacokinetics and pharmacodynamics and, thus, the efficacy and safety of drugs used in
women with pregnancies is currently limited.
The primary objective of the proposed project is to narrow this knowledge gap using betamethasone as a
prototypical paradigm compound. First, we will develop physiologically-based pharmacokinetic (PBPK) models
for twin monochorionic and dichorionic twin pregnancies (Specific Aim #1). We will incorporate pregnancy-
specific changes, including the induction of CYP3A4 by elevated 17β-estradiol levels in twin pregnancies. Using
clinical data from both singleton and twin pregnancies, we will establish dose-exposure-response relationships
for betamethasone and RDS prevention in the fetus through the integrated use of model-based meta-analysis
(MBMA) and PBPK modeling and simulation approaches. This will allow us to propose optimal dosing and dose-
to-delivery intervals for betamethasone to prevent RDS in twin pregnancies (Specific Aim #2). Our research will
support drug label improvement, as the current use of betamethasone in RDS is still off-label. Ultimately, our
research will generate quantitative insights into this underrepresented population, refining the dosing strategies
for betamethasone and paving the way for safer, more effective treatments for high-risk twin pregnancies.

Public health relevance
PROJECT NARRATIVE Twin pregnancies, which make up about 3% of all U.S. births, are associated with unique challenges in clinical pharmacology due to physiological differences that can affect how drugs work in the body. This project aims to optimize the use of betamethasone, a drug used to prevent respiratory complications in premature babies, by using advanced computer models to predict the best dosing strategies specifically for twin pregnancies. By improving drug safety and effectiveness, this research will help reduce complications in twins and support better health outcomes for both mothers and babies.